Expanding BioThings as a community API gateway for sharing biomedical knowledge

In biomedical research, effective analysis of new experimental data depends on the contextualization of results
using the totality of biomedical knowledge known to date. This existing knowledge is often organized in
structured knowledge bases (KBs). These KBs are instrumental in interpreting new data, and subsequent
conclusions are often integrated back into the KBs to stimulate future discoveries. This positive-feedback loop
has benefited multiple areas of biomedical research, given the rich availability of both high-throughput data and
derived knowledge in recent decades. While development of technologies for data generation remains a
primary way to drive research forward, improvements to the efficiency of making available data/knowledge
Findable, Accessible, Interoperable and Reusable (FAIR) also has a significant impact for the future
advancement in biomedical research. In this proposal, we propose to build a distributed ecosystem of
biomedical Application Programming Interfaces (APIs) for promoting FAIR data-sharing and knowledge
integration. This ecosystem contains a framework for API creation; an API registry for API management and
discovery; and a semantic annotation and integration framework to create cross-API interoperability for their
reuse. Beyond promoting the FAIR principles, the distributed nature of this API-based data ecosystem also
allows distributed implementation and maintenance efforts for its long-term sustainability. The utility of the
ecosystem will be demonstrated in broad areas of research use-cases.

Public health relevance
Successful biomedical research relies on the effective integration of available knowledge known to date. We propose to enhance our existing software platform to build a distributed knowledge ecosystem to promote data-sharing and knowledge integration at scale, with its utility demonstrated in broad research use cases.